Waters ACQUITY UPLC M-Class with NanoLockSpray ionization source

ABSTRACT The current equipment supplement request is for an upgrade of the current mass spectrometry platform to enable nano-scale liquid chromatography. Active grants R01 GM099989 (PI: Lee), and R01s GM130810 and GM121603 (PI: Atkins) jointly request the funds for a Waters M-class HPLC with the corresponding NanoLockSpray ionization source. The upgrade will provide the enhancement in sensitivity to overcome the limits in sensitivity and material requirements that have hindered analytical characterization of numerous the proteins of interest. This will dramatically increase the range of systems and samples we can analyze. The equipment will be shared equally among three NIGMS-funded PIs while being managed and maintained by the School of Pharmacy Mass Spectrometry Facility.

Public health relevance
NARRATIVE Membrane associated proteins perform a wide range of critical biological processes including drug metabolism, transport, and enable viruses to enter host cells. However, few techniques exist to probe the solution structure of the proteins as they exist in their native membrane environments. This supplement request will enable us to develop a more sensitive analytical platform for rapidly analyzing drug metabolizing enzymes and viral surface glycoprotein structures within native membranes which will provide a much- needed tool for identifying relevant targets for therapeutic intervention.